Satisfaction of Search in Breast Cancer Detection

PROJECT SUMMARY/ABSTRACT
Breast cancer has the highest incidence of cancer for women in the U.S. and across the world. Despite
advances in technology—from film-screen images to Full Field Digital Mammography (FFDM) and now to
Digital Breast Tomosynthesis (DBT)—the yearly miss rate has remained stubbornly stable, ranging between
10-30% at screening. Technology alone is not reducing errors of omission; we need to understand the specific
challenges faced by the human readers interpreting the images, and the specific errors that they lead to.
Satisfaction of Search (SOS) refers to the fact that, after having detected a first lesion in a case, the
miss rate for additional lesions in the same case is substantially elevated. This specific type of error has been
shown to account for 30% of misses in the domains of Radiology where it has been studied, including chest
radiography and Computed Tomography. And yet, it has never been studied in the domain of breast cancer.
Thus, there is a critical need to determine how SOS contributes to errors in breast cancer screening.
In the present project we will determine the rates of occurrence and the underlying causes of SOS in
FFDM and DBT. We have devised a novel method that overcomes limitations of previous methods and that is
optimized for use in FFDM and DBT. Previous approaches to studying SOS involved the photographic addition
of artificial lesions to images, which is not feasible for breast imaging. Instead, we will construct a database of
naturally occurring cases that is structured for studying SOS. This will involve the collection of multiple-lesion
cases and controlled single-lesions cases, where the former are matched with the latter on key diagnostic
dimensions, such as lesion type, lesion size, and breast density. In two main experiments (one with FFDM and
one with DBT), radiologists will read cases from the experimental set, marking the locations and diagnoses for
benign and malignant lesions. Signal-detection analyses over dual- and single-lesion cases will be used to
estimate the rate of SOS. Eye position and pupil diameter will be tracked as participants read each case.
These data will allow us to assess the prevalence of different known causes of SOS: (a) premature
termination, in which search following first lesion detection is less comprehensive compared with single-lesion
control cases; (b) perceptual set, in which, after having detected a first lesion, participants are biased to find
subsequent lesions with similar perceptual features, leading to reduced sensitivity in the detection of
perceptually dissimilar targets; and (c) resource depletion, in which the demands of maintaining information
about a first-detected lesion in memory reduce available perceptual/cognitive resources, thereby reducing the
efficiency of subsequent search. Understanding the rates and underlying causes of SOS in breast cancer
detection will lay the foundation for planned future work to develop training programs and best practices that
mitigate the specific causes of SOS errors and thereby reduce miss rates in breast cancer screening.

Public health relevance
PROJECT NARRATIVE The term “Satisfaction of Search” (SOS) refers to the phenomenon that one or more lesions are missed after a first lesion has been reported in an image, and SOS is responsible for up to 30% of all misses in the domains where it has been studied, such as chest radiology. However, SOS has never been studied in breast imaging, despite breast cancer being the most common type of cancer among women worldwide. In this project we will study SOS in full-field digital mammography (FFDM, a 2d image) and in Digital Breast Tomosynthesis (DBT, a pseudo-3d image), and determine the rate of these errors and their underlying causes.